Host Factors for Rhinovirus

PROJECT ABSTRACT
We aim to define host factors that are associated with the more virulent human rhinoviruses (RV), RV-A and RV-
C. Although RV are the most frequent cause of the common cold, they also provoke more severe manifestations,
particularly in those with underlying lung disease. RV are the most frequent cause of asthma exacerbations,
specifically induced by RV-A and RV-C, and only rarely RV-B. We have found that RV-A and RV-C require the
host factor Stimulator of Interferon Genes (STING) for replication of their genome, while RV-B do not. Although
STING is an immune adaptor critical for immune sensing in DNA viruses, its importance during RNA infections
is becoming increasing recognized. In humans, STING1 exists as multiple variant alleles containing one or more
single nucleotide polymorphisms. The most common STING variant is deficient in type I interferon (IFN-I)
signaling, while other common variants have reduced IFN-I. As RV are restricted to only infect humans, we have
found that for RV-A and RV-C, STING is a restricting host factor. While human STING robustly supports RV-A
and RV-C replication, murine STING does not. The three Aims of the Project will explore the mechanism for
STING host factor activity, determine how natural STING alleles influence RV-A and RV-C replication, and
identify which nonstructural components of the virus interact with STING or the STING complex to promote
infection. By studying the host factor role of STING during RV replication, the proposed research will define
factors important for the increased virulence between RV species in this important human pathogen.

Public health relevance
PROJECT NARRATIVE Rhinovirus (RV) is an important pathogen that in addition to causing the common cold, cause severe manifestations of lung disease including asthma and COPD exacerbations. The numerous RV species are not equally virulent in their capacity to induce asthma exacerbations. This project will analyze STING, an RV host factor for the more virulent species, by deciphering its mechanism, and its role in immune signaling during infection.